ANALYSIS OF CORD BLOOD FROM HIV INFECTED MOTHERS

The study proposes to determine whether sufficient quantities of progenitor cells obtained from umbilical cord blood (CB) can be stratified, genetically engineered to be HIV-resistant, and banked for future use in treating HIV-infected infants. It will evaluate (1) CB cells from mothers stratified for CD4+ cell count for primitive hematopoietic cells and viral burden; (2) the efficiency of retroviral transduction into CB cells; (3) the anti-HIV effect of regulated toxin genes in CB cells; and (4) how freezing and thawing effects CB cells.